Elucidating molecular mechanisms of PARP2 at R loops in myelodysplastic syndromes

ABSTRACT
Myelodysplastic syndromes (MDS), a group of blood disorders diagnosed in nearly 15,000 Americans annually,
are characterized by patients with high-risk MDS having a median survival of less than two years. Roughly half
of all MDS patients possess a mutation in an RNA splicing factor (SF) gene: most commonly U2AF1, SRSF2, or
SF3B1. Mutations in U2AF1 and SRSF2 are associated with faster disease progression to secondary acute
myeloid leukemia and with poorer patient outcomes. Complicating treatment, MDS-associated SF mutations are
mutually exclusive and cause unique patterns of alternative splicing events with non-overlapping outcomes,
based on the individual mutations. Overcoming this, previous work in the Nguyen lab identified R loops, three-
stranded RNA:DNA hybrid transcription intermediates, as a unifying mechanism of disease pathogenesis
induced by MDS-associated SF mutations. Recently, the lab further found that SF mutations sensitize cells to
inhibitors of poly(ADP-ribose) polymerase (PARP) enzymes, and that PARP1 plays a vital role in regulating R
loops and maintaining genomic stability in SF-mutant cells. The proposed project aims to expand on this prior
work by elucidating the mechanism by which PARP2 regulates R loops in cells possessing MDS-associated SF
mutations. Preliminary results show that PARP2 associates with R loops, and that loss of PARP2 leads to both
a reduction in ADP-ribosylation signaling in SF-mutant cells, and R-loop accumulation. In contrast, loss of PARP2
had no effect on ADP-ribosylation levels following direct DNA damage alone. PARP2 was also found to interact
with the R-loop-resolving helicase DDX41. The central hypothesis of this project is that PARP2 plays a unique
role at R loops to prevent R-loop-associated genomic instability in SF-mutant cells. This hypothesis will be tested
through two specific aims evaluating PARP2 function at R loops: 1) elucidate how PARP2 senses R loops in
U2AF1S34F cells, and 2) determine the impact of DDX41 ADP-ribosylation at R loops in SF-mutant cells. Results
obtained through completion of these aims will provide new insights into how cells maintain genomic stability in
response to R-loop accumulation, explicate a mechanism by which PARP inhibitors sensitize SF-mutant cells,
and potentially identify novel biomarkers to predict this sensitivity. This proposal will be completed at the
University of Minnesota, under the co-mentorship of Dr. Hai Dang Nguyen, an expert in the DNA damage
response, R-loop regulation, and hematologic disorders, and Dr. David Largaespada (co-sponsor), an expert in
molecular-genetic mechanisms of pathogenesis. To complement this expertise, I will receive further guidance
from my collaborators: Dr. Stanley Lee, who specializes in mouse models of splicing-factor mutant MDS, and Dr.
Anthony Leung, an expert in ADP-ribosylation signaling. This mentorship team, paired with the collaborative
research environment, provides a unique opportunity for the candidate to complete the research aims described
in this proposal and achieve his goal of becoming a molecular translational scientist working to uncover
mechanisms of pathogenesis in hematologic disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE Roughly half of all patients with myelodysplastic syndromes (MDS), a group of blood disorders diagnosed in nearly 15,000 Americans each year, have a mutation in an RNA splicing factor gene—with mutations in two of the most commonly affected genes, U2AF1 and SRSF2, being associated with poorer patient outcomes. Through studying the mechanism by which the DNA repair enzyme PARP2 regulates R loops, this project aims to elucidate a genomic maintenance pathway which could be targeted to selectively kill cells possessing MDS- associated splicing factor mutations. Building on past work from our lab, the results of this project will provide new insights into how cells maintain genomic stability in response to aberrant R-loop accumulation: explicating a mechanism by which FDA-approved PARP inhibitors sensitize splicing-factor mutant cells, and potentially identifying novel biomarkers that confer this sensitivity.